Grem1 and Grem2 in embryonic ovary development

PROJECT SUMMARY
Normally, women undergo menopause in their early fifties due to exhaustion of the pool of oocytes called
the “ovarian reserve”. Oocytes are generated in large numbers during embryonic development, but the vast
majority undergo programmed cell death; the remaining oocytes become enclosed within quiescent primordial
follicles that make up the ovarian reserve. Pathologic development of the ovarian reserve leads to infertility or
early reproductive senescence. Furthermore, meiotic errors in oocytes cause germ cell death or result in
developmental defects such as aneuploidy. The molecular signals within the embryonic ovary that determine the
upper and lower limits for oocyte numbers are unknown. The long-term goal of our laboratory is to identify
signaling pathways that control oogenesis and thus, female reproductive lifespan. The bone morphogenetic
proteins (BMPs) are a large subgroup of the transforming growth factor beta family and have conserved roles in
primordial germ cell specification and development. The BMPs are known morphogens whose activity must be
strictly regulated during development or pathology and disease results. There are a number of secreted
extracellular BMP-binding proteins that act as molecular sinks to negatively regulate the amount of BMP “sensed”
by a signal-receiving cell. Two of these BMP antagonists, GREMLIN-1 and GREMLIN-2 have genetic variants
associated with primary ovarian insufficiency (POI) in women. We tested the developmental role of Grem1 and
Grem2 by generating single and double knockout mice for Grem1 and Grem2. These mice display a range of
defects in embryonic ovary development including changes to oocyte number and altered meiosis. The aims of
this proposal are designed to (1) determine how loss of Grem1 and/or Grem2 alters embryonic ovary
development; and (2) determine which signaling pathways are dysregulated in embryonic ovaries of mutant mice
that drive changes in germ cell numbers. Collectively, our studies stand to uncover fundamental mechanism that
regulate embryonic ovary development and oocyte numbers, which are essential for mammalian female
reproduction and reproductive lifespan.

Public health relevance
NARRATIVE Infertility is a significant health concern for 15% of the general population with the women representing approximately half of those cases. Defective oocyte development during the formation of the ovarian reserve likely contributes to infertility and changes to female reproductive lifespan. The goal of these studies is to determine how Gremlin-1 and Gremlin-2 direct somatic and germ cell development in the fetal mouse ovary using novel genetic models. 1